Measuring the nanoscale molecular environment dictating the transcriptional state of the Epidermal Differentiation Complex

PROJECT SUMMARY
In the stratified epithelia, each layer of cells exhibits a distinct and tightly regulated chromatin organization
and gene expression profile. During epidermal differentiation mechanical signals from the extracellular matrix
and linker of the nuclear-envelope linker of the cytoskeleton (LINC) are propagated to the nucleus, correlating
with a change in chromatin organization and expression. These events coincide with the marked transcriptional
activation of a 3.1 Mb chromosomal region known as the epidermal differentiation complex (EDC), which
contains genes that are a hallmark feature of differentiation. However, the mechanism by which mechanical
force impacts or regulates gene activation and silencing remains unclear. In this proposal, I will use the
EDC as a framework by which to investigate the mechanism by which direct force and/or nuclear lamina
associated proteins are necessary and sufficient to inhibit or activate gene expression in epidermal
differentiation.
Activation of the EDC is characterized by a change in nuclear localization, chromatin organization, and shift
in associated proteins. However, the spatial organization of these partners remains unresolved. I will apply a
new single-molecule superresolution technique that will simultaneously image EDC-associated proteins,
histone modification, and the EDC at nanometer scales (<25nm) (Aim1). By doing this I will be able to
measure the spatial distance between individual targets to create a map of the nuclear environment in mouse
keratinocytes in which the EDC is either in the active or repressed chromatin state.
To investigate the mechanism by which nuclear localization influences gene expression of the EDC, I will
apply a synthetic inducible tethering system by which EDC localization can be biophysically manipulated (Aim
2). In wild-type mouse keratinocytes it has been shown that the EDC occupies different nuclear localizations in
the active and repressed state but the mechanism that regulates this remains unknown. I will evaluate in wild-
type keratinocytes and keratinocytes in which LINC-complex dependent tension has been ablated and EDC
expression is active, if tethering/localization to the nuclear periphery is sufficient and necessary in inhibiting
expression.
The completion of these aims will uncover the relationship between chromatin organization and gene
expression in the context of epidermal differentiation. Thus far, this structure and function relationship has
been correlative; by applying and developing new technology I have the unique ability to reveal mechanistic
insight into the nanoscale molecular environment that dictates the transcriptional state of the epidermal
differentiation complex in normal and pathogenic states.

Public health relevance
PROJECT NARRATIVE The epidermis is composed of layers of cells with distinct structures and functions, where each cell undergoes tightly coordinated changes in genomic organization and expression. Misregulation of these coordinated changes has been shown to lead to pathogenic states such as psoriasis and atopic dermatitis. My proposal will use novel microscopy techniques to define and uncover the mechanisms that regulate this structure-function relationship.